Biochemistry, biology and diversity of Fic domains

Project Summary
A variety of cellular processes are commonly subverted to encourage the proliferation of cancer cells,
one of which is the unfolded protein response (UPR) that occurs in the endoplasmic reticulum (ER).
Importantly, there is also a strong connection between UPR and inflammation or neuronal health.
Many neurodegenerative diseases and diseases of aging have connections to the UPR. We have
recently discovered a new form of BiP regulation, AMPylation by the protein Fic. We observe that Fic
adds an adenosine monophosphate (AMP) molecule to a threonine near the ATP binding site of BiP
during normal growth conditions. This modification rapidly is removed by the same enzyme Fic under
multiple ER stress-inducing conditions. We recently have shown that the regulation of BiP by Fic is
essential for maintaining neuronal homeostasis. Since our discovery of Fic domains that mediate
AMPylation, other diverse activities performed by bacterial Fic domains have been identified. These
studies have revealed the molecular plasticity of Fic domains in its ability to utilize diverse substrates.
Despite these studies, there are many different Fic proteins that remain to be characterized, both in
catalytic activity, biological function, and molecular targets. We propose three projects that will further
our understanding of the biology of Fic enzymes and the chemistry they use, both in vitro and in vivo.
First, when the ER is stressed, Fic changes from an AMPylator to a deAMPylator, and the key to this
regulation is breaking a salt bridge in Fic's active site. We want to understand the biochemistry
regulating this switch. Second, our studies with Drosophila genetics show that Fic is required for
neuronal plasticity. We are therefore interested in understanding what role Fic plays in mammalian
biology using transgenic mice. Third, there are many different Fic proteins that remain to be
characterized, both in catalytic activity, biological function, and molecular targets. We plan to
investigate these orphan Fic domains and identify their biological activities and substrates.

Public health relevance
Project Narrative Since our discovery of Fic domains that mediate AMPylation, other diverse activities performed by bacterial Fic domains have been identified. In metazoans, Fic regulates by reversible AMPylation another protein called BiP(GRP78), which is an essential chaperone found in the endoplasmic reticulum that helps to maintain homeostasis in healthy cells. Our goal is to understand how Fic's activity is regulated, why it has been conserved in mammals and what other chemistries are used by orphan Fic domains.